Metabolic control of global gene expression during the Maternal-to-Zygotic Transition

ABSTRACT After an egg is fertilized, many thousands of genes are turned on in the embryo while maternal mRNA is degraded; this process is called the maternal to zygotic transition (MZT). The goal of this proposal is to decipher how activation of zygotic genes is synchronized with maternal mRNA decay. Both histone modifications and the mRNA modification N6-methyladenosine (m6A) play prominent roles, during the MZT, by regulating transcription of zygotic genes and maternal mRNA clearance, respectively. However, the signals that control changes in chromatin and mRNA modifications in this critical developmental stage are largely unknown. This proposal will test the novel hypothesis that changes in cellular metabolism coordinate global gene expression during the MZT, through the availability of metabolites required for chromatin and mRNA modifications. Using high-resolution mass-spectrometry, in Drosophila (D). melanogaster embryos during the MZT, we identified changes in the levels of alpha-ketoglutarate (a-KG), which is a required co-factor for histone and RNA demethylation enzymes. Here, we test our central hypothesis through the following specific aims: (1) test the link between a-KG levels, histone methylation, and global transcription activation of zygotic genes, and (2) test the link between a-KG levels, m6A modification of mRNA, and maternal mRNA decay. D.melanogaster embryos are an ideal system for studying the interplay between metabolism and gene regulation because there are many experimental tools for manipulating and measuring metabolism, chromatin state, mRNA modifications and transcription in vivo. This proposal will apply molecular, genetic and genomic approaches to demonstrate how metabolic inputs, such as a-KG, shape the developmental transcriptome and coordinate critical developmental processes by controlling both chromatin and mRNA modifications. Findings from this study will be relevant for understanding diseases in which metabolic dysfunction is associated with abnormal gene expression, such as cancer and diabetes. Establishing D.melanogaster as an experimental platform for studying metabolic regulation of global gene expression and acquiring the relevant set of skills as part of this research plan will be a critical next step towards fulfilling my goal of becoming an independent investigator.

Public health relevance
NARRATIVE To execute development properly, many thousands of genes must be coordinately expressed. This study will investigate how changes in metabolism can regulate such global gene expression programs through control of metabolic intermediates, which are required to modify chromatin and mRNA. Our findings will be essential for deciphering how metabolic dysfunction may lead to disease and how metabolism can be targeted for therapeutic intervention.